Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM (DRP): ABSTRACT
The Developmental Research Program (DRP) is an essential component of the Prostate SPORE, providing
yearly funding to 4-6 projects that are peer reviewed and deemed to have promising translational potential.
Funding is flexible, supporting projects for a period of two years or less. It is expected that DRP investigators
will develop and advance their pilots sufficiently to either replace main projects that are not progressing or will
secure independent funding in prostate cancer research. Of note, all three projects presented in the renewal
have emanated from pilot projects and propose translating discoveries made in the investigators’ labs to the
clinic. The DRP follows a highly structured process to solicit projects from investigators who are interested in
developing projects in the area of prostate cancer, to review projects according to NIH review criteria and to
monitor projects for scientific progress. The DRP is maintained throughout the entire period of SPORE funding.
The specific aims of the Developmental Research Program are:
• Specific Aim 1: To solicit, review and select innovative and translational pilot projects through the highly
structured process. A request for applications (RFA) is sent out to investigators at the Northwestern University
(NU), University of Chicago and its affiliated NorthShore University HealthSystems. The Scientific Review
Committee reviews pilot projects based on the quality and importance to the overall SPORE mission.
• Specific Aim 2: To monitor progress of pilot projects within the context of the overall SPORE goals. Pilot project
investigators are required to present their results twice per year at SPORE investigators meeting. They also
meet twice per year with the Directors of the DRP to obtain translational insight and to ensure that scientific
milestones are being achieved. DRP investigators are required to submit a written progress report that is
rigorously evaluated by the SPORE PI and members of the Executive Committee.
• Specific Aim 3: To encourage and recruit additional investigators to pursue research in prostate cancer through
a SPORE web site and by widely distributing the RFA announcing the availability of funds. Women and minority
investigators are strongly encouraged to submit pilot projects.
• Specific Aim 4: To maintain the administrative process for the Developmental Research Program throughout
the SPORE funding period.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM (DRP): NARRATIVE The SPORE Developmental Research Program provides yearly funding to 4-6 projects that have promising translational potential. It is anticipated that investigators who develop their pilots sufficiently may replace main projects that are not progressing or will secure independent funding in prostate cancer research.